Immunologic memory to metabolic cycling

The prevalence of obesity and associated co-morbidities, including type 2 diabetes and
cardiovascular disease (CVD), has increased dramatically in the past several decades. While weight
loss is the ideal approach to reduce the negative metabolic consequences of obesity, it is clear that
sustained weight loss is difficult to achieve. In fact, only 20% of people who lose at least 10% of their
body weight are able to maintain that loss for greater than 2 years. These bouts of weight loss
followed by subsequent weight gain lead to “weight-cycling”. Interestingly, several studies in humans
demonstrate that weight-cycling increases the risk of developing metabolic diseases. While the
potentially deleterious effects of weight-cycling are recognized, the mechanisms by which weight-
cycling increases metabolic dysfunction remain unknown. During the past decade, we have come to
understand that the immune system plays a key role in the pathological consequences of obesity.
Metabolic organs such as the liver, muscle, and adipose tissue (AT) accumulate immune cells that
subsequently impact the insulin sensitivity of the parenchymal cells. In particular, obesity results in a
dramatic increase in the number of inflammatory AT macrophages and AT T lymphocytes (ATTs).
Interestingly, the accumulation of T cells in obese AT appears to be antigen-driven and is also
characterized by the formation of memory cells. To determine if weight cycling alters immune
responses in AT, we developed a mouse model of weight cycling using alternating high fat (HF) and
low fat (LF) diet feeding. Similar to what is seen in humans; the weight-cycled mice had increased
fasting glucose levels and impaired systemic glucose tolerance compared to mice that gained weight
but did not cycle (weight-gain controls). Furthermore, AT-specific insulin signaling was abolished in
the weight-cycled mice. At the end of the study, the macrophage populations in AT were unchanged
in their number and phenotype. However, ATT number and the expression of multiple TH1-associated
genes were significantly increased in the AT of the weight-cycled mice. These data demonstrate that
weight cycling induces a potent T cell-driven adaptive immune response in the AT and suggest that
weight cycling actually induce a secondary adaptive immune response. Thus, the overall hypothesis
of this application is: weight-cycling results in an accelerated secondary adaptive immune
response that heightens inflammation in AT, leading to local and systemic insulin resistance.
This hypothesis will be tested in the following 3 aims: 1) To determine whether weight cycling alters
ATT phenotype and function; 2) To determine if weight cycling induces secondary immune responses
in AT; 3) To determine whether weight cycling modulates regulatory T cell (Treg) phenotype and
function.

Public health relevance
Project Narrative Obesity has become a worldwide epidemic resulting in increased incidence of many different diseases. Recent evidence suggests that weight cycling is associated with elevated risk of diabetes and cardiovascular disease. As such, scientific discovery toward understanding the mechanisms by which weight cycling has adverse metabolic effects is of utmost importance.